Short term heart, lung, blood research opportunities

ABSTRACT
This research education program offers short-term support to underrepresented or disadvantaged
undergraduate and medical school students to provide them with career opportunities in cardiovascular,
pulmonary, hematologic or sleep research. The research activity will expose trainees to the excitement,
challenges and rewards of a career in biomedical research that are not otherwise available in their regular course
of study. The CWRU short term HLB program will provide mentored research training with outstanding
investigators in these four areas to 12 undergraduates and 8 medical students each year. The overall goal of
this training program is to increase diversity among students who pursue academic careers in medicine and
science, particularly in cardiovascular, pulmonary, hematologic and sleep research. This goal will be pursued by
(1) helping trainees develop research skills, identity with the scientific profession and confidence in a research
environment through well structured, mentored short term experiences that lay the foundation for biomedical
research in clinical and bench settings, (2) providing exposure to diverse areas of research relevant to NHLBI
(in particular, health disparities) and leaders in research with guest lectures and student presentations.
Undergraduates from around the nation will be selected from more than 100 or more online applications each
year after competitive review, and matched with researchers for 2 months on a full-time basis as summer
research trainees. Medical students largely from this institution will be selected on the basis of the quality of the
research proposal, the strength of the advisor as a research mentor and role model and the potential for a
positive research experience and spend 2 full time months during the summer. Both groups of trainees will attend
common weekly sessions and interact to build a community of peers. Our faculty lead outstanding programs that
encompass basic, translational, clinical, population-based research programs in cardiovascular, pulmonary,
hematologic and sleep research, and each has an outstanding training record and strong interest in working with
students. Our evaluation system allows us to continuously improve our training program, and our database and
tracking plan highlights the achievements and career outcomes of our trainees.

Public health relevance
PROJECT NARRATIVE The CWRU Short-Term Heart Lung and Blood Research Opportunities program will provide key support for underrepresented minority and disadvantaged undergraduate and medical students in research education in order to expose students to biomedical challenges in cardiovascular, pulmonary, hematologic and sleep research. This experience, coupled with additional activities will strengthen their confidence as researchers, bolster their competiveness for subsequent graduate and medical programs, and encourage students to continue academic research.